BETA BLOCKER EVALUATION OF SURVIVAL TRIAL

To determine whether the addition of betablockers to standard therapy for congestive heart failure reduces total mortality of patients with moderate to severe chronic heart failure.